Mechanisms controlling stochastic gene expression during eye development

Project Summary: Lineage and signaling mechanisms specify cell fates, often yielding stereotypical patterns of
cell types. In some contexts, these inputs regulate fate choices in a probabilistic way to produce random patterns.
The mechanisms controlling stochastic cell fate specification, in which a cell randomly chooses between fates
with a set probability, are poorly understood. Stochastic cell fate specification is critical for the generation of
photoreceptors, olfactory receptors, motor neurons, interneurons, immune cells, and stem cells. Breakdowns
cause disorders, including vision impairments, anosmia, autism, immunodeficiencies, and lymphoma. The main
goal of this project is to determine how cell-intrinsic mechanisms including transcription and chromatin regulation
(Aim 1) and extrinsic mechanisms involving cell-cell signaling (Aim 2) control stochastic fate specification.
The fly eye is an ideal paradigm to study stochastic fate specification because its development involves
a simple, random, binary fate choice. The retina contains a random mosaic of two R7 photoreceptor subtypes,
controlled by the stochastic expression of the transcription factor Spineless (Ss), yielding SsON and SsOFF R7s.
How transcriptional regulation and chromatin compaction are integrated to turn genes randomly on or off
during development is poorly understood (Aim 1). We found that an enhancer drives ss transcription in precursor
cells to open the ss locus. Transcription ceases and the ss locus compacts in a subset of cells. In terminal R7s
in which chromatin compacts, ss is repressed. In R7s with open chromatin, ss is reactivated. As transitions in ss
transcription and chromatin states are critical for this fate choice, we developed strategies to study ss in live,
developing eyes. To understand how the dynamics of ss expression influence R7 subtype fate, we will examine
ss transcription using a reporter system. To relate the dynamics of transcriptional and chromatin states, we will
use DNA visualization systems to mark the ends of the ss locus and simultaneously live image transcription and
chromatin compaction. To determine the roles of transcription and chromatin factors, we will examine ss
regulation in mutant conditions. As features of this mechanism are observed in bacteria and mouse, our studies
will characterize fundamental mechanisms controlling stochastic cell fate specification across species.
The stochastic mosaic of R7 subtypes is overlaid on the stereotypical morphology of the fly eye, providing
the opportunity to study how development of these patterns intersects (Aim 2). Hedgehog (Hh) and
Decapentaplegic (Dpp) signaling, together with the transcription factor Homothorax (Hth), generates the regular
morphology of the eye. We found that the Hh-Dpp-Hth network regulates stochastic ss expression. To address
how this network regulates ss, we will use mutant and ectopic expression strategies to determine the roles of
pathway members. To understand how noise affects R7 subtype and morphological patterning, we will increase
and decrease variability by ablating or ectopically expressing genes in mosaic clones. Our studies will reveal
how a single mechanism coordinates stereotypical and stochastic patterning within the same developing tissue.

Public health relevance
Project Narrative Stochastic fate specification, in which a cell randomly chooses between two or more fates, is critical for diversifying visual photoreceptors, olfactory receptors, motor neurons, immune cells, and stem cells. Breakdowns in these regulatory mechanisms contribute to vision disorders, anosmia, autism, immunodeficiencies, and lymphoma, emphasizing the need to investigate the molecular underpinnings of this biological process. Using the fly eye as a model, we will characterize the roles of transcriptional and chromatin dynamics and cell-cell signaling in stochastic photoreceptor fate specification.